Developing a Novel Analytical Toolbox to Tackle Multifaceted Statistical Challenges in Analyzing Post-Fracture Recovery Trajectories in Older Adults with ADRD

Project Summary/Abstract
Older adults diagnosed with ADRD are up to three Ɵmes more likely than cogniƟvely intact older adults to sustain a hip
fracture, and paƟents with ADRD have poorer funcƟonal outcomes, greater disability and dependency, and spend more
than 50 fewer days at home in the year aŌer fracture. However, this growing populaƟon is highly heterogeneous with
some paƟents experiencing very slow to very fast recovery, which precludes proacƟve risk straƟﬁcaƟon, hinders shared
decision making, and thwarts opƟmal transiƟonal care support. Given the signiﬁcant costs and consequences of hip
fractures among older adults, improving recovery trajectories for those with ADRD is a crucial naƟonal priority.
Unfortunately, clinical characterisƟcs and hospital-level factors associated with longitudinal post-fracture recovery in this
populaƟon are poorly understood, hindering the development of eﬀecƟve and personalized transiƟonal care strategies.
Moreover, hospitals oŌen obtain access to Medicare data and outcomes on their clinical populaƟons, but how eﬀecƟvely
they can use this data for quality improvement is in quesƟon, which reﬂects a major missed opportunity to both improve
and tailor care for older adults, parƟcularly those with ADRD. Untangling mulƟ-level variabiliƟes within the populaƟon of
paƟents with ADRD is criƟcal because they could be the target of more individualized caregiving strategies to promote
aging in place, facilitate resource allocaƟon among hospitals, and enable the advancement of precision healthcare. To
this end, we will develop, validate, and apply novel analyƟcal methods in data science, which include proposing machine-
learning assisted high-dimensional regression, computaƟonally eﬃcient individualized dynamic predicƟon, and mulƟ-
algorithm-based robust causal inference methods: Aim 1: Develop a novel machine learning-assisted method for
idenƟfying unique paƟent characterisƟcs leading to poor longitudinal recovery outcomes in geriatric seƫngs with mulƟ-
level structured data. Aim 2: Develop a novel joint modeling approach for mulƟ-level and mulƟ-variate outcomes:
uncovering shared mechanisms and facilitaƟng individualized dynamic outcome predicƟon. Aim 3: Develop a new
method of ML-algorithm ensemble to idenƟfy causal factors, as potenƟal target for health system-level and pragmaƟc
intervenƟons to enhance recovery outcomes. Aim 4: Leverage Medicare data from >20,000 paƟents treated by over 1000
hospitals to understand mulƟlevel variabiliƟes of post-fracture recovery outcomes for older adults living with ADRD. The
proposed method can eﬀecƟvely handle high dimensional data, address mulƟple biases due to informaƟve clustering at
mulƟple levels (healthcare facility, individual, observaƟon) and truncaƟon by death, and outperform exisƟng methods
and lead to unbiased analyses that disentangle mulƟ-level variability of post-fracture outcomes. Signiﬁcance is enhanced
by developing and releasing soŌware (e.g., R packages) to increase the methods’ uptake among the scienƟﬁc community.
The ulƟmate impact is to enable individualized predicƟon for older adults living with ADRD and promote Ɵmely strategies
to improve caregiving for detected high risk cohorts.

Public health relevance
Project Narrative This project aims to develop an innovative analytical toolbox designed to address multifaceted statistical challenges inherent in the analysis of real-world data. Utilizing this toolbox to analyze Medicare data will yield insights into the identification of high-risk subgroups and hospital-level factors partially driving poor post- fracture recovery trajectories for older adults living with ADRD. Consequently, these findings will enhance predictive capabilities for multivariate and multilevel outcomes, enabling the development of personalized caregiving strategies for new patients.